Disaster Research Response (DR2) Core

Disaster Research Response (DR2) Core ABSTRACT
The overall theme of the Texas A&M University Superfund Research Center is to develop, apply,
and translate a comprehensive set of tools and models that will aid in mitigating the human health
consequences of exposure to hazardous mixtures during environmental emergency-related
contamination events. In the past funding period (since 2017), the Center responded to a number
of disasters to collect samples and respond to concerns from community partners, nongovernmental
organizations, and local and state agencies. Activities included sampling of water,
sediment, and soils in response to Hurricane Harvey (2017), Hurricane Florence (2018), and the
large-scale industrial fire at the Intercontinental Terminals Company (ITC) facility (2019). Sampling
was conducted to establish both spatial and temporal dimensions of the extent of re-distribution of
hazardous substances in the environment that may impact human health. While several of the
Texas A&M University Superfund Research Center’s projects and cores have contributed to these
efforts and provided sampling supplies, field personnel, training, and quality assurance/control
(QA/QC) documentation, we now propose to establish a dedicated service core for these activities.
Therefore, this new DR2 Core will support the Center, and the rigor and reproducibility of its DR2
activities, by ensuring the Center’s ability to respond to disasters through creation of a centralized
resource to support DR2 infrastructure, methods, supplies, and training. The central hypothesis of
the DR2 Core is that the rigor and reproducibility of DR2 activities will be ensured and the Center’s
ability to respond to future disasters with translational research will be improved by creating a
centralized resource and infrastructure to support disaster research response encompassing
environmental assessment capabilities that can be rapidly deployed anywhere. The DR2 Core
responds to Superfund mandate (3), the development of methods and technologies to detect
hazardous substances in the environment, and will focus on four specific Aims. First, the DR2 Core
will maintain sampling supplies, field and laboratory equipment, and instrumentation required for
collection of environmental samples during and after disasters. Second, the DR2 Core will
coordinate collection, processing, and storage of environmental samples. Third, this Core will
facilitate DR2 activities by the projects and cores and integrate with NIH DR2 programs. Finally,
the DR2 Core will ensure that Center personnel can conduct fieldwork safely and properly for
baseline sampling and in response to disasters. Overall, the efforts of the DR2 Core will specifically
enhance interactions among Center projects and other cores, increasing their impact by ensuring
alignment of measured/human/test system exposures from real-life environmental samples and
increasing the translation of basic science in decision making, translation, and community
engagement.

Public health relevance
Disaster Research Response (DR2) Core NARRATIVE The Texas A&M University Superfund Research Center is engaged in a number of disaster research response (DR2) activities and deployed personnel to a number of disasters to collect samples and respond to concerns from community partners, non-governmental organizations, and local and state agencies. Activities included sampling of water, sediment, and soils in response to Hurricane Harvey (2017), Hurricane Florence (2018), and the large-scale industrial fire at the Intercontinental Terminals Company (ITC) facility (2019). Therefore, this new DR2 Core will support the Center, and the rigor and reproducibility of its DR2 activities, by ensuring the Center’s ability to respond to disasters through creation of a centralized resource to support DR2 infrastructure, methods, supplies, and training.